CRCNS:US-lsrael Research Proposal: To Elucidate Fundamental Mechanisms of Transformed Saliency Map to

The neural bases of sensory stimulus selection, an essential function for attentional and adaptive
behavior, will be investigated by this collaborative project in barn owls, a specialized stimulus
localizer species. While a topographic representation of relative stimulus strength and behavioral
relevance across visual and auditory space has been demonstrated in the barn owl's optic tectum
(OT), how the information is conveyed to downstream decision-making centers for proper control
of stimulus driven behaviors is unknown in barn owls, as well as in other species. The main goal
of the proposed research is to understand the read-out mechanisms of the midbrain map in the
ascending midbrain-to-forebrain pathway, along which a transformation involving abolishment of
a topographic representation of spatial location is observed. Barn owls offer a strong advantage
for investigating these questions, because of their robust and well-studied visual and auditory
representations across brain regions and because a robust auditory saliency map has been
shown in the barn owl. This study aims at answering the question of how behaviorally relevant
sensory signals are selected and encoded to induce stimulus location driven perceptual and
behavioral responses while others are ignored. Through simultaneous recordings of midbrain,
thalamic and forebrain regions, the hypothesis that topographic representation of salient stimuli
is translated into a non-topographic representation of salient stimuli for both visual (Aim 1) and
auditory (Aim 2) salient stimuli will be tested in both anesthetized and behaving animals.
Computational modeling describing network processing and coding will be used for further testing
hypothesis and detailed description of network and coding mechanisms underlying
transformational coding of stimulus selection (Aim 3). Preliminary results support feasibility of
proposed approaches. This collaborative computational project will contribute intellectual merits
and broader impact of widening view and understanding of neural coding and network
mechanisms underlying stimulus selection by a transformational coding scheme from midbrain to
forebrain, fundamental for selective attention and perception of salient stimuli across species.
Innovative simultaneous recordings of midbrain and forebrain regions of anesthetized and awake
animals, and interdisciplinary physiological, behavioral and computational approaches will be
implemented. In addition, training opportunities and publication goals for undergraduate, graduate
and postdoctoral fellows will enhance their visibility and career plans.

Public health relevance
Conceptual significance: Results of this research are expected to have high impact on our understanding of mechanisms of processing and coding of salient stimuli along sensory pathways. The proposed research project aims to test fundamental qualitative changes in coding frameworks of auditory and visual pathways and investigate underlying processing and information flow mediating these changes, a novel and promising research that could explain how salience of sensory inputs is processed and encoded in the brain, which is fundamental to how we perceive and interact with the world around us. Technical significance: The proposed action uses innovative multielectrode recording techniques in awake and behaving animals to understand flow of information and coding of salient stimuli from midbrain to forebrain audiovisual regions. In addition, it will implement and interdisciplinary approach, combining recording of neuronal population responses and computational modeling of coding and processing schemes.